Integrated Omics Analysis of Pain: Omics Data Generation Center

The Omics Data Generation Center (ODGC) proposed in this application is a collaborative effort of three academic institutions with complementary technical expertise, experience in large-scale data generation projects, and established collaborations and interactions: Wake Forest University Health Sciences (WFUHS) in Winston-Salem, NC, Duke University School of Medicine (Duke) in Durham, NC, and the University of California (UCD) in Davis, CA. The Administrative Core of the ODGC will coordinate the effective operation of the entire ODGC across the three performance sites, facilitate interaction and communication between all Cores and Components of the ODGC, and monitor progress of the data generation and analysis. Furthermore, the Administrative Core will interact with the Multisite Clinical Centers, the Data Integration and Resource Center, and another ODGC (if another is funded) of the A2CPS Consortium to coordinate sample and data transfer, and maintain communications to coordinate all activities with NIH and the A2CPS Consortium. Specifically, it is the goal of the Administrative Core to: a) Coordinate, monitor, and safeguard the entire operations of the ODGC, from sample requests to final omics data transfer, and to ensure that all data collected can be seamlessly integrated and analyzed. b) Coordinate interactions with the entire A2CPS Consortium, its individual Centers, and NIH to ensure that the Consortium accomplishes the overall goals of the A2CPS effort. To accomplish these goals, the Administrative Core of the ODGC is creating four Teams that will operate across the individual Cores and Components of the ODGC: 1. The Leadership Team, (Tim Howard, PhD, Carl Langefeld, PhD, Michael Olivier, PhD, Oliver Fiehn, PhD). 2. The Pain Expert Team (James Eisenach, MD, Wolfgang Liedtke, MD, PhD, Yusuke Shiozawa, MD, PhD, Roy Strowd, MD). 3. The Sample Coordination Team (Nichole Allred, PhD, Laura Cox, PhD, Hector Guillen, PhD). 4. The Data QC and Analysis Team (Carl Langefeld, PhD, Ellen Quillen, PhD). All Teams of the Administrative Core of the ODGC will be supported by an experienced administrative support team at the WFUHS Center for Precision Medicine, and all efforts will be coordinated by the ODGC Program. Coordinator, Claudia Olivier, PhD. The Administrative Core will work closely with the A2CPS Consortium to ensure the successful completion of the ODGC goals.